Role of IgA-biome in intestinal dysbiosis and brain changes in Alzheimer's disease

Summary
An estimated 6.2 million individuals have Alzheimer’s disease (AD) in the US, which is projected to nearly triple
by 2050. Although genetic and several environmental factors help explain the etiology of AD, emerging reports
recognize significant associations between altered diversity, abundance, and composition of the intestinal
microbiota, intestinal dysfunction, loss of epithelial barrier integrity, and the progression of AD. However, it is
difficult to distinguish associations from causal relationships. Nevertheless, it is apparent that the dysbiotic gut
microbial community elicits inflammatory features extending beyond the enteric system and stimulates aberrant
and pathological brain changes. Intestinal homeostasis relies on secreted IgA that coats pathogenic bacteria
and blocks their contact with epithelial receptors to avert inflammatory responses. We will test the idea that
IgA-coated bacteria (IgA-biome) in the dysbiotic intestine are pathogenic and responsible for the direct
potentiation of AD. Our preliminary data using a transgenic AppNL-G-F mouse model of AD demonstrated a
significant increase in the levels of IgA-coated fecal bacteria in female mice. Moreover, 16s rRNA sequencing
of IgA sorted bacteria (IgA-seq) from 12-month-old female AppNL-G-F and C57BL/6 wild-type mice identified
distinct differences in the microbial taxa coated by IgA. These data were concomitant with behavior changes
seen only in the female AppNL-G-F mice suggesting a nexus between the IgA-biome, gut, and brain. We will fully
characterize the longitudinal changes in the IgA-biome by IgA-seq in Aim one and determine whether distinct
IgA coated bacteria correlate with changes in immune phenotype, memory, gliosis, and β-amyloid
accumulation. In Aim two, we will validate the role of IgA in the dysbiosed AD gut by oral gavage transfer of
IgA-biome from old into young mice and assess sex and genotype-dependent changes in behavior, gliosis, β-
amyloid accumulation, and peripheral and intestinal immunomodulatory changes. Our work will provide a new
understanding of the IgA-biome as a contributor to brain changes in AD and may be relevant to other
neurodegenerative conditions. We will also identify the unique age and disease patterns of IgA-biome taxa that
can be potential diagnostic biomarkers and therapeutic targets.

Public health relevance
Narrative Alzheimer’s disease (AD) is a devastating age-related neurodegenerative disorder that causes extensive deterioration of cognitive functions. Altered gut bacteria and their effects on the gut, immune system, and brain have been recently implicated as causative in disease. The IgA isotype antibody produced predominantly in the gut is the primary protection in the intestine from harmful pathogens such as bacteria. Using a mouse model of disease, we demonstrate that female AD mice have elevated IgA in the intestine that recognizes unique disease- associated bacteria capable of producing memory dysfunction. We hypothesize that these IgA coated bacteria are directly contributing to disease in particularly females and will test this in the proposal. Completion of the study will identify pathogenic gut bacteria contributing to AD progression in a sex-selective fashion.